CULTURALLY CENTERED TREATMENT FOR OUD IMPLEMENTATION FOR ADDICTION TREATMENT PROGRAMS SERVING AMERICAN INDIAN/ALASKA NATIVES (CTN-0096). DSC5 CONTRACT. 09/20/2019 - 11/15/2022. N01DA-19-2250.

CULTURALLY CENTERED TREATMENT FOR OUD IMPLEMENTATION FOR ADDICTION TREATMENT PROGRAMS SERVING AMERICAN INDIAN/ALASKA NATIVES (CTN-0096).